Assessing the mediating role of kidney function and weight/BMI in the association between INSTI use and blood pressure changes and hypertension in PWH: a secondary analysis of the REPRIEVE study.

Project Summary
Our R03 application critically evaluates cardiovascular risks associated with integrase strand transfer inhibitors (INSTIs),
focusing on blood pressure and hypertension among people living with HIV. Utilizing data from the REPRIEVE
(Randomized Trial to Prevent Vascular Events in HIV) study, our project aims to address significant gaps in the current
understanding of these risks. Aim 1 employs a novel target trial framework to emulate randomized trials using the
REPRIEVE dataset, in which INSTI use was not originally randomized. This innovative approach enables the application of
advanced causal inference techniques, specifically inverse probability of treatment weighting and inverse probability of
censoring weighting, to rigorously assess the effects of INSTIs. These techniques help us adjust for confounding variables,
enabling us to draw robust conclusions about the causal impacts of INSTI use on blood pressure. Through this aim, we
expect to gain clear insights into the direct effects of INSTIs on cardiovascular health. Aim 2 employs causal mediation
methods to dissect the pathways through which INSTIs influence blood pressure. This aim focuses on understanding how
changes in kidney function and body mass index mediate these effects. By exploring both direct and indirect effects of
INSTIs, mediated through physiological changes, we deepen our understanding of how these drugs impact cardiovascular
systems in clinical settings. Our study is distinguished by its global scope, incorporating data from diverse international
settings, including South Africa, Brazil, Botswana, Thailand, and the United States. This wide-reaching approach enhances
the generalizability of our findings and enables comparative analyses across different geographic and economic contexts.
Such comparisons are critical for understanding how systemic health disparities affect the relationship between INSTI use
and cardiovascular outcomes. By including data from both high-income and lower-income countries, our study is uniquely
positioned to highlight differences in health outcomes and healthcare practices. These insights will allow us to identify
specific challenges and opportunities in managing HIV and related comorbid conditions across varied health systems. The
methodological innovations and geographic diversity of our research will significantly contribute to the scientific
understanding of HIV treatment complications. By generating actionable insights, we aim to inform clinical practices and
influence public health policies globally. Ultimately, securing this R03 grant would enable us to make substantial
contributions to international health guidelines, significantly improving the management of HIV and comorbid conditions
such as hypertension through tailored interventions.

Public health relevance
Project Narrative Our R03 application utilizes innovative epidemiological methods to investigate cardiovascular risks, including hypertension and changes in blood pressure, linked to integrase strand transfer inhibitors (INSTIs) in people living with HIV. Using the REPRIEVE dataset, we will employ a target trial framework to emulate randomized trials, addressing the non-randomized use of INSTIs, and apply advanced causal inference techniques to directly assess their impact on blood pressure changes and hypertension risk. Additionally, we will use causal mediation methods to explore how kidney function and body mass index influence the cardiovascular effects of INSTIs, thus deepening our global understanding of modern HIV treatment and its associated comorbidities in diverse populations.